Training Grant in Cell and Molecular Dermatology

This is a competing renewal application of a training grant currently in its 41st year. The overall goal of this
proposal is to train postdoctoral M.D. and Ph.D. fellows for academic careers in investigational dermatology.
Its first objective is to provide laboratory training for dermatology-trained physicians. Its second objective is
to train Ph.D. basic scientists in laboratory-based translational investigative dermatology. Its third objective is
to train M.D. dermatologists and Ph.D.s in clinical and translational research. Trainees will commit to a
minimum of two years of research training, which will occur under the supervision of one of thirteen primary
preceptors. Laboratory-based fellows (M.D. and Ph.D.) will learn to formulate hypotheses and to design,
perform, and analyze experiments, utilizing a multidisciplinary approach that emphasizes the use of human
skin tissue as an experimental system. M.D. trainees in clinical/translational research will acquire proficiency
in hypothesis-driven clinical research design and methods and in statistical analysis of data, while gaining an
appreciation of the basic science knowledge underlying their clinical observations and interventions. To
maximize multidisciplinary training, and to broaden our outreach into the broader University community, we
have added highly qualified primary preceptors from outside the Department of Dermatology. In addition to
mandatory participation in selected departmental didactic activities, introductory and advanced courses in
clinical research methods and a molecular biology course for clinician-scientists will be available for trainees
through the Medical School and the Michigan Institute for Clinical and Health Research (MICHR). Also, face-to-
face training in the responsible conduct of research will be provided at the departmental and University-wide
levels. In order to attract more dermatologists into academic careers, we have incorporated research
fellowship opportunities in cutaneous oncology, appearance-based dermatology, and dermatopathology. We
have also changed our resident selection procedure in order to identify and attract NRSA-eligible M.D.s with
strong research potential. We have also added a MICHR-sponsored Translational Research Training Program
for Ph.D.s. We also maintain a Web site for dissemination of detailed information about our program to all
potential trainees.
By training M.D.s and Ph.D.s in state-of-the-art dermatological research at both the basic and clinical-
translational levels, we will maximize the clinical impact of research, enhance the abilities of our trainees to
teach future physicians, and increase the basic knowledge upon which our specialty increasingly depends.

Public health relevance
PROJECT NARRATIVE This program is designed to train both physicians and basic scientists in the biology of the skin and in the study of skin diseases including psoriasis and other autoimmune skin conditions, aging, and skin cancer. All of these problems are common in the United States and have major impacts on public health. We have a particular focus on "bench to bedside" research that connects what we know about skin biology to patients with skin diseases, in order to deliver better treatments as well as prevention.